Mentoring Multidisciplinary Patient-Oriented Research in Liver Disease

Abstract
Dr. Khalili is an established investigator and mentor as evidenced by her high-quality patient-oriented
research, mentoring activities of young investigators, and her institutional leadership roles in research
mentoring. Her long-term career objectives are: 1) to support and train early clinical investigators to transition
to independent careers in multidisciplinary research, 2) to enhance effectiveness of research mentors to
better meet the needs of their mentees, and 3) to lead efforts in better understanding of mechanisms of host
and environmental interactions important to pathogenesis and progression of liver disease. During the next
project period, she will use initial successes of the last project period to further expand her research and
mentoring program, thereby increasing the pool of new investigators that successfully transition to
independence. Dr. Khalili's multidisciplinary research program supported by continuous extramural funding
will serve as the platform for providing mentorship for junior investigators from different disciplines. Moreover,
she plans to lead national training efforts to enhance research mentor and mentee self-efficacy and mentee
productivity especially among underrepresented groups in biomedical sciences. In the next project cycle she
will capitalize on the rich academic environment of UCSF and its Clinical and Translational Sciences Institute
resources to train mentees from different disciplines to enable them to compete successfully for mentored
career development and independent awards in patient-oriented research. While the value of mentoring has
been well-established, better understanding of which components of mentoring are most impactful on mentee
success and implementing these strategies in training mentors are also critical to their young investigator
career development. Dr. Khalili will use her leadership role in the UCSF Mentor Training Program to advance
mentor training approaches through evaluation and program enhancement that build capacity of research
mentors to effectively mentor young investigators and especially those from underrepresented backgrounds.
Insulin resistance is an important contributor to negative impact of chronic liver diseases on human health
and adipose tissue dysfunction has emerged as important to pathogenesis of liver disease. During the first
project period, we gained insights into host, alcohol, and viral interactions influencing pathogenesis of
abnormal glucose metabolism. The research plan for the next project period will extend these investigations
to evaluate the influence of alcohol on adipose-tissue liver axis using chronic hepatitis C as a model of a
common liver disease with high rates of adverse metabolic outcomes and in utilizing validated and direct
measurements of insulin resistance in adipose tissue in at-risk populations. This research plan and resources
from Dr. Khalili's ongoing research activities will provide mentoring and training opportunities for new and
junior clinical investigators in patient-oriented multidisciplinary research in liver disease. The continuation of
this award will allow Dr. Khalili to achieve these mentorship and research goals.

Public health relevance
Project Narrative This award will support mentoring of early stage investigators in performing patient-oriented multidisciplinary research in alcohol, liver disease, and metabolism and their transition to independent researchers. The high prevalence of obesity in United States and the related dysfunction of adipose tissue have emerged as significant contributors to adverse outcomes of chronic liver disease. The studies outlined in this proposal will elucidate the impact of alcohol on adipose tissue-liver axis in at- risk populations with and without hepatitis C infection.